Poly(pro-Estrogen) Microneedle Patches

Project Summary
This R03 application is focused on creation of an innovative microneedle patch (MNP)
composed entirely of a polymerized 17β-estradiol (E2), the major female sex hormone. The
macromolecular pro-drug materials are cured thermosets in which every repeating unit in the
polyester chains contains an equivalent of E2. These crosslinked polyester resins undergo slow
hydrolytic degradation to release low doses of estrogen, locally at the site of implantation, for
exceptionally long time periods (up to many years). Transdermal microneedle patches offer
minimally invasive, painless administration of estrogen. These delivery methods enhance patient
compliance relative to repeated injections with hypodermic needles and they require lower doses
than oral administration due by avoiding first-pass hepatic clearance. Of all the many advanced
MNP technologies, there are still no examples of MNPs composed entirely of poly(pro-drug). Our
lab has developed a new class of polymerizable estrogen pro-drugs containing pendant alkene
groups. In this proposal, we will polymerize the pro-E2 monomers in a microneedle mold. A key
innovation is that we plan to tune the glass transition of the polymer network such that the needles
are hard and glassy at room temperature for skin penetration, but then they transition into a
soft/rubbery material upon equilibration to physiological temperature.
This project is likely to make significant contributions by developing new poly(pro-drug)
based microneedle patches capable of releasing low doses of E2 transdermally for exceptionally
prolonged timescales. The chemistry and engineering approaches used here will be broadly
generalizable in two key ways: 1) our polymerization scheme is easily modified to accommodate
nearly any drug molecule with two or more reactive functional group handles, and 2) the MNP of
poly(pro-E2) can be applied to a broad range of clinical applications where prolonged low-dose
E2 is desired. Our goal for future work is to apply these E2-releasing MNPs in a preclinical rodent
model to first assess safety and skin irritation and later to explore the impact of the patch on
functional recovery from contusive spinal cord injury.

Public health relevance
Project Narrative Microneedle patches (MNP) are an emerging technology for painless, low-dose, prolonged drug delivery. Polymerized drugs, i.e. poly(pro-drug)s, are a unique class of macromolecules composed almost entirely of a pro-drug molecule in long chain repeating sequences. In this application, we propose to develop the first ever MNP composed of a poly(pro-drug), specifically crosslinked thermosetting polyester resins of pro-17β-estradiol for prolonged low-dose estrogen delivery.